Administrative and Research Translation Core

PROJECT SUMMARY: Administrative and Research Translation Core
The Iowa Superfund Research Program (ISRP) is a highly integrated research center focusing on the sources,
exposures, toxicities, and remediation of polychlorinated biphenyl (PCBs) congeners in air. The integration
across biomedical and environmental science and engineering disciplines requires organizational infrastructure
to enable the frequent, regular exchange of ideas, experiments, and data among projects and cores. The major
goal is to maintain a structure that promotes research integration, enables timely communication, and supports
research translation that raises the quality and impact of center activities. The Administrative and Research
Translation Core (ARTC) provides vision and direction to ensure continued success in research and
stakeholder engagement. To meet this goal, the ARTC has three aims: 1) Provide program leadership and
infrastructure to ensure synthesis of findings and integration of activities. Director Hornbuckle and Deputy
Director Lehmler are leading environmental health researchers with backgrounds in environmental engineering
and biomedical science, respectively. The ISRP Executive Committee, composed of leaders from every
program component and representing diverse disciplines, works with Hornbuckle and Lehmler to ensure full
integration and coordination among projects and cores. The leadership actively promotes frequent and regular
researcher interactions both inside and outside the ISRP through monthly meetings, seminars, and events.
The ARTC conducts annual assessments of productivity, effectiveness, and integration for each project and
core to guide recommendations from the External Advisory Committee (EAC), which is composed of nationally
recognized Superfund researchers and other stakeholders. 2) Provide administrative and fiscal services,
support, and oversight to ensure robust stewardship of available resources. The Director, together with the
Center Administrator and Fiscal Manager, provide programmatic and financial services, support, and oversight.
3) Disseminate ISRP scientific and environmental health discoveries through effective research translation.
The ISRP is dedicated to making center research available and accessible in consideration of the SRP
research translation objectives: a) communication with SRP and SRP staff; b) partnerships with government
agencies; c) technology transfer; and d) information dissemination to other end-users, with a particular focus
on communicating in the manner most appropriate for each audience. If the ISRP is renewed, regular activities
will include social media news feeds; webinars and training workshops; decision-support tools for communities,
agencies, and organizations managing PCBs surrounding Superfund sites and schools; web applications to
disseminate research findings; and development of new technology and platforms to maximize bi-directional
communication.

Public health relevance
NARRATIVE- Administrative and Research Translation Core The Administrative and Research Translation Core promotes and integrates research, enables research translation, and provides vision and direction to the Center. ISRP’s research and engagement focus on airborne PCBs found in school buildings and emitted from contaminated waters and soils of Superfund sites. The ISRP examines the potential health impact of inhaled PCBs, particularly on adolescents, and with focus on neurodevelopmental and metabolic effects